Establishing a Mechanism for the Autophagic Degradation of Nuclear Components and its Relationship to Aging

Project Summary/Abstract
Autophagy is a protective cellular mechanism with the capacity to maintain organelle homeostasis and thereby
delay cellular and organismal aging. Interestingly, recent work suggests that degradation of components of the
nucleus may be important for maintaining chronological lifespan (CLS). Consistent with this, there are many
long-standing genetic links between the nucleus, and components of its bounding membranes, with aging.
Thus, a priority for the field is to fully understand the nuclear autophagy (nucleophagy) mechanism to more
fully define how clearance of nuclear components contributes to aging and age-related disease. However,
there is no defined nuclear cargo adaptor in mammals making isolating the role of nucleophagy from
autophagy more challenging. By contrast, a nucleophagy cargo adaptor, Atg39, has been identified in budding
yeast providing an opportunity to investigate the nucleophagy mechanism and its role in maintaining CLS in
this model organism. Key questions include which proteins are required for nucleophagy and how the nuclear
envelope (NE) is remodeled to generate a subdomain of the nucleus competent for capture by
autophagosomes. The goal of this proposal is to define key mechanistic steps in nucleophagy and provide
insight into its potential role in slowing aging. I will achieve these goals by using proximity-labeling and Mass
Spectrometry to identify proteins that cooperate with Atg39 to drive nucleophagy. The contribution of these
proteins to nucleophagy will be determined by measuring nucleophagic flux in targeted gene deletions as well
as colocalization experiments using live-cell fluorescence microscopy, which will inform the spatial and
temporal dynamics of the function of each protein. The second aim will utilize an innovative combination of
Bimolecular Fluorescence Complementation (BiFC) and Correlative Light Electron Microscopy (CLEM) to study
the steps of nucleophagy at the resolution of the ultrastructure.

Public health relevance
Project Narrative Autophagy is a catabolic cellular process that selectively eliminates damaged and superfluous cellular contents to maintain homeostasis and delay aging. The mechanisms that govern autophagic degradation of components of the nucleus remains ill defined. Here, we intend to provide new mechanistic insight into nucleophagy and how disruptions in this process impacts lifespan.